BRIDGES TO THE BACCALAUREATE DEGREE

Cancer, diabetes, kidney failure and cardiovascular, lung and blood diseases are annually responsible for several million deaths, high morbidity and tremendous economic costs in the United States alone. Minorities and blacks in particular, suffer unproportionally higher devastating effects from the aforementioned diseases than whites. The problem is greatly compounded in Mississippi, which is one of the poorest states in the nation. The exceptionally high impact of these disorders on minority populations, results from a multitude of factors including a high percentage of economically disadvantaged minority families and an inadequate number of minority health care professionals and basic science researchers trained in biomedical science areas. The purpose of the proposed Bridges to Baccalaureate Degree Program (BBDP) is to motivate and prepare 2-year community college students to enter and successfully complete research training programs leading to the baccalaureate degree in Biomedical areas. The Program will expand established cooperative, inter-institutional and interdisciplinary training program between Jackson State University, (a historically black institution) and Hinds Community College (a 2-year college). The Program will utilize Faculty and Administrators at each institution in the planning, implementation and programmatic aspects including 1. Provision of functional Steering and Advisory committees, 2. Development and implementation of student selection and advisement procedures, and 3. Conceptualization, implementation and publicity of research findings. All HCC students will enroll in an Introduction to Research course that will provide training in research and laboratory methodologies, literature survey mechanisms, and scientific writing techniques. Students will engage in specific individualized research projects and collaborate with faculty and co- trainees on additional projects. Students will be required to orally present their research findings at local seminar and professional meetings. They will also be encouraged to submit research manuscripts to biomedically related peer reviewed journals for publication. Faculty participants at each institution will travel to local scientific conferences with student trainees where appropriate. Students will be exposed to biomedical, professional, and career experiences. They will also receive assistance in application procedures for baccalaureate degree programs in biomedical schools.